MicroRNA Regulation of Phospholipid Homeostasis in Alzheimer's Disease Pathogenesis

PROJECT SUMMARY
APOE4 is the strongest genetic risk factor for sporadic AD with Ab-dependent and Ab-independent effects on
disease pathogenesis. However, the molecular mechanisms underlying the pathogenic nature of APOE4 in AD
are not fully elucidated. In previous funding period (07/01/2017-present), we have made significant progress
toward understanding micro-RNA (miRNA) regulation of APOE4-induced brain phospholipid dysregulation in AD.
We have uncovered a novel regulatory mechanism of miR-195 targeted at APOE4-associated cognitive deficits
and lysosomal defects in AD. Notably, we identified miR-195 as a top miRNA candidate involved in the APOE-
regulated brain phosphoinositol biphosphate (PIP2) pathway using human ROSMAP and mouse microarray data.
Levels of miR-195 are significantly lower in APOE4+ human and mouse brains, and in human inducible
pluripotent stem cells (iPSC)-derived neurons and astrocytes when compared to APOE4- counterparts. Over-
expressing miR-195 reduces expression levels of its top target synaptojanin 1 (synj1), the brain PIP2 degrading
enzyme. Elevating miR-195 ameliorates cognitive deficits and AD pathology in APOE4+ mice and rescues
lysosomal defects in APOE4+ iPSC brain cells. Furthermore, our preliminary results support the role of miR-195
as an anti-inflammatory miRNA in regulating microglial function. Our single cell (sc)-RNA seq. analysis of E4FAD
mouse brains with miR-195 over-expression suggests that miR-195 alters molecular signatures of microglia sub-
clusters. APOE4+ microglia with lower miR-195 levels and higher synj1 expression at baseline, manifests with
impaired phagocytic activities and lysosomal defects when compared to APOE3+ microglia. Down-regulation of
synj1 or over-expression of miR-195 can rescue these phenotypes. Beside synj1, inflammatory genes pdcd4
and smad7 are predicted targets of miR-195 as well. Over-expression of miR-195 in microglia inhibits
lipopolysaccharide (LPS)-induced increases in smad7 and pdcd4 expression, attenuates LPS-induced
proinflammatory cytokine release and augments anti-inflammatory responses. In addition, exosomes derived
from APOE4/4 astrocytes (ADEs) contain less miR-195 than those in APOE3/3 ADEs, and over-expression of
miR-195 in APOE4/4 astrocytes increases miR-195 levels in ADEs which can attenuate LPS-induced pro-
inflammatory cytokine release. Therefore, we hypothesize that miR-195 may exhibit anti-inflammatory effects
through down-regulation of microglial synj1 to regulate lysosomal function, direct target at microglial inflammatory
gene expression and responses, and modulation of neuro-inflammation and tau spread by exosomal miR-195.
We propose to characterize the regulation of microglial function by miR-195 during AD pathogenesis in this
renewal application. We will: 1) determine the impact of miR-195 on microglia function and APOE-regulated
neuro-inflammation in AD in vivo (Aim 1) using cuprizone (CPZ)-induced inflammation in male and female EFAD
mouse models (human ApoE4 knock-in at 5xFAD background); 2) to characterize the molecular mechanisms by
which miR-195 regulates AD-associated neuro-inflammation (Aim 2) using microglial culture and 3-D co-culture
system of mouse brain cells from EFAD and APOE KI mice, as well as from synj1-/-, APOE-/- and TREM2-/- mice
(with manipulations of miR-195 levels); 3) to perform high resolution multiscale network modeling using scRNA-
seq dataset from mouse brains (Aim 1) and RNA-seq and miR-seq datasets from microglia and 3-D co-culture
system (Aim 2) to identify microglia-specific molecular signatures driven by miR-195; and 4) to validate identified
microglial signature driven by miR-195 in postmortem human brain samples and investigate their correlation with
the development of AD-associated neuro-inflammation during disease progression (Aim 2). The goals of this
application aim to elucidate novel pathways and molecular signatures driven by miR-195 protective against
APOE4-induced microglial dysfunction in AD pathogenesis, which will facilitate identification and development
of a more personalized targeted therapeutic approach to AD-associated neuro-inflammation.

Public health relevance
PROJECT NARRATIVE The molecular mechanisms underlying the pathogenic nature of APOE4 in Alzheimer’s disease (AD) are not fully elucidated. In previous funding period, we have uncovered a novel regulatory mechanism of miR-195 targeted at APOE4-associated cognitive deficits and lysosomal defects in AD. Our preliminary results further support the role of miR-195 as an anti-inflammatory miRNA in regulating microglial function. Therefore, we will characterize in this renewal application, the regulation of microglial function in AD by miR-195 with in vivo studies of humanized APOE mouse models, ex vivo microglial culture and 3-D co-culture system, and validation studies of human brain samples. The scRNA-seq data from mouse brains and RNA-seq/miRNA-seq data from mouse microglial and 3-D co-culture will be integrated to perform high resolution multiscale network modeling and to elucidate novel molecular signatures driven by miR-195 protective against APOE4-induced neuro-inflammation.